Sleep in Neurocognitive Aging and Alzheimers Research (SANAR)

Latinos have up to a fourfold risk of Alzheimer's disease and related dementias (ADRD) compared to non-
Hispanic whites. Further, ADRD onset occurs earlier in Latinos and is often accompanied by vascular risk factors.
Consistent with the NIA Alzheimer's prevention Initiative, we will focus on two vascular risk factors never studied
in Latino ADRD prevention studies: obstructive sleep apnea (OSA) and non-dipping of blood pressure (NDBP).
Over the last decade, OSA has been shown to increase mortality, stroke and vascular disease (e.g. NDBP).
OSA is also linked with a 26% increase in cognitive decline or ADRD. However, most studies are limited by the
use of self-reported data, measured OSA at a single time point or studied older adults, which do not preclude
the possibility of reverse causation. Our published data from the Hispanic Community Health Study/Study of
Latinos (HCHS/SOL; N≈16,000 at Visit-1), shows that OSA is associated with worse cognitive function,
especially in females<55 years. Of interest, OSA had strong associations with prevalent (OR 2.1) and incident
hypertension (HR 1.5). In clinical studies, NDBP was more common than clinic hypertension and had stronger
associations with stroke and cognition; yet there is no information in the high-risk Latino population. There is an
imperative to examine whether OSA in midlife is causal to late life cognitive decline in Latinos, the largest U.S.
minority group; findings of important

Public health relevance
SANAR will have a significant public health impact, in particular to Latinos, who are the largest US ethnic/racial group. Compared with U.S non-Hispanic whites, neurocognitive decline occurs earlier in Latinos, and is often accompanied by hypertension and cerebrovascular disease. Targeting novel vascular risk factors, such as obstructive sleep apnea that has potent associations with non-dipping of blood pressure and cerebrovascular injury, presents a unique opportunity to help prevent neurocognitive decline and reduce Latino dementia.